Global TravEpiNet (GTEN): the Heading Home Healthy Program and Global Travelers' Health National Research Center Consortium, Guidance and Outreach Programs

PROJECT SUMMARY/ABSTRACT International travel may not only increase the risk of infection for an individual traveler, but may also contribute to the global spread of infections. A better understanding of this epidemiologically important population could lead to improved interventions (1) to promote the health of international travelers, and (2) to diminish the spread of infections within home communities. This application focuses on proposed efforts for the Global Travelers' Epidemiology Network (Global TravEpiNet; GTEN). GTEN's mission is to lessen illness among high-risk international travelers, including VFR travelers, and to reduce the likelihood of disease importation into the United States. GTEN is comprised of two components: (1) a consortium of over 20 clinical sites that collects real-time data on pre-travel health care provided across the United States (since inception: over 80,000 records have been collected), and (2) a public health outreach program (“Heading Home Healthy”; www.headinghomehealthy.org) that includes web-tools and educational materials in multiple languages for high risk and VFR travelers, as well as a clinical guidance tool for non-expert providers who deliver the majority of pre-travel care to such travelers. We propose to expand upon the existing infrastructure developed by GTEN in order to (1) answer fundamental questions relating to the health care of US residents who travel internationally, and (2) improve the pre-travel health care provided to vulnerable US populations at highest risk of travel-related illness.

Public health relevance
PROJECT NARRATIVE International travel may not only increase the risk of infection for an individual traveler, but may also contribute to the global spread of infections. This renewal application focuses on Global TravEpiNet -- a consortium of clinics providing pre-travel health advice, and the driving force behind the Heading Home Healthy Program. GTEN's mission is to advance the care of US international travelers, with the goal of preserving and advancing the health of the American public.